Impact of Schwann Cell Pathology on Axon Structure and Function

Reciprocal interactions between axons and Schwann cells (SCs) drive the formation, function, and maintenance
of myelinated nerves, which are essential for effective saltatory conduction and neurologic function. Extrinsic
signals from the axon and the basal lamina (BL) cooperatively drive expression of a series of SC transcription
factors (TFs), culminating in the expression of Egr2, the master regulator of PNS myelination. Egr2 is required
for SCs to advance from the promyelinating stage, when they wrap axons once, to myelination, when they
upregulate myelin components and form the multilamellar myelin sheath. Myelinating SCs in turn re-organize
axons into distinct domains, in particular the node of Ranvier, and increase axon size. These collective changes
enable and optimize action potential propagation by saltatory conduction. The importance of this regulation of
axon biology by SCs is underscored by the disability associated with acquired and inherited (e.g., Charcot Marie
Tooth (CMT) disorders of myelinating SCs (mSCs). CMTs that result from various SC mutations cause
de/dysmyelination characterized by slow nerve conduction velocity (NCV), often with nerve conduction block
(NCB). Pathologic features of CMTs typically include inflammation, hypertrophic changes, reduced axon
diameters and (distal) axon loss. The resulting neurological disability can range from minor to severe. How SC
defects drive this array of cellular pathologies and what mechanisms underlie the clinical spectrum of CMTs are
key questions with important translational implications. To interrogate how SC pathology impacts axon biology
and leads to clinical defects, we are characterizing mice in which two key SC proteins, Egr2 and the G coupled
protein receptor, Gpr126 have been deleted. Conditional knockouts (cKOs) of either of these proteins arrest SCs
at the promyelinating stage and blocks their ability to form myelin. Yet these mice have very different phenotypes:
Gpr126 cKOs are mildly affected and have a normal life span whereas Egr2 cKOs are progressively paralyzed
and moribund by 3-4 months of age. As expected, NCV is markedly slow in both mutants. However, only the
Egr2 cKOs exhibit frank NCB, a likely driver of their severe disability. Correspondingly, these mutants have very
distinct nerve pathologies. Egr2 cKOs nerves are markedly inflamed, hypertrophic, and their axons are
significantly smaller as compared to Gpr126 cKOs. To further elucidate differences between these mutants, we
will investigate: i) the role of inflammation in their respective phenotypes and why these dysmyelinating SCs
differentially activate inflammation, ii) examine the mechanisms by which these SC mutations regulate axon
diameter and iii) use single nuclei RNAseq to characterize changes in the transcriptomes of SCs that impact
axon biology and function in nerve conduction. These studies should provide important new insights into how
SC pathology impacts axon biology and function and may lead to new therapeutic strategies to ameliorate
disability in disorders of myelinated fibers.

Public health relevance
Narrative This study examines the various effects of Schwann cell pathology on the structure and function of axons in nerve conduction, using genetically modified mice that model inherited human neuropathies. Unexpectedly, these mutations demonstrate that failure to form myelin is not the chief cause of their neurological disability but rather, other factors, including inflammation of their nerves, are critical. Determining how these mutant Schwann cells differentially impact axon biology and nerve inflammation should aid in developing new therapeutic strategies for peripheral neuoropathies.